BIOPHYSICAL PARASITOLOGY

This project is concerned with analyses of the genetic diversity of medically important parasitic protozoa and its implications to the epidemiology, course, and diagnosis of disease. The project has become increasingly involved in elucidation of diversity at the DNA level. We are refining a method we developed to synchronize the DNA synthetic cycle of trypanosomatids using very high levels of hydroxyurea. We will utilize the technique for the production of large quantities of synchronized cells for elucidation and analyses of cell cycle-specific and developmental stage-specific substances. We have identified an oligonucleotide which appears to differentiate between stocks of Trypanosoma cruzi at the DNA level. We are attempting to complete feasibility studies of the use of a microcalorimeter to study metabolic processes in intact protozoa.